DHEA REPLACEMENT IN ADDISONS DISEAES--ANABOLIC PARAMETERS

Determine the beneficial effects of a replacement dose of DHEA on anabolic parameters in patients with Addison's Disease. Study anabolic parameters including somatotropic axis and DEXA scans for bone mineral density.